The effects of early acoustic hearing for pediatric cochlear implant recipients

Clinicians are now focused on which device, at each ear, best provides the perceptual acuity such that age-
appropriate spoken language develops. Bilateral CIs (BCIs) are recommended as soon as possible for young
children with the most profound hearing losses (HLs). Clinicians are less certain, however, about
recommendations for young children with HL varying from severe to profound. Although the long-term
consequences of these device decisions are unknown, the expectation is that early perceptual abilities provide
a foundation for functional communication and peer interactions critical for navigating academic and social
situations in a hearing world. Generally, hearing-device recommendations are based on audiometric thresholds
and speech perception scores, usually segmental speech scores (e.g., words understood). Yet
suprasegmental perception (perception of intonation, stress, and rhythm), which is also extremely important for
spoken language and lexical development, has been largely ignored. Importantly, the acoustic cues associated
with suprasegmental perception are not transmitted equally well with CIs and HAs; CIs are typically more
effective for conveying segmental cues while HAs, depending on a listener's residual hearing, are more
effective for conveying suprasegmental cues. We identified a critical duration of HA use for each of three
ranges of HL severity (pure-tone-averages [PTAs] of 72, 92 &110 dB HL) that maximizes both segmental and
suprasegmental perception. Both contribute to receptive language, and suprasegmental remains significant for
early reading skills. Our results suggest that a child with severe HL (~72 dB HL) who receives BCIs at an early
age, and consequently does not experience early extended use of a HA, could be denied good
suprasegmental perception and a more-typical language foundation. The long-term benefits, however, of early
HA use (moderated by PTA) to spoken language skills, reading, and other perceptual abilities remain
unknown. We now propose to establish whether early HA use contributes to, or detracts from, perception skills
implicit in “real world” communication, namely audiovisual (AV) speech perception and binaural listening. Early
acoustic hearing complements visual speech information and may provide large benefits for AV perception.
Alternatively, for developing binaural listening skills, early BCIs, with their somewhat symmetrical stimulation,
may be better than bimodal devices for which there is an implicit extended period of acoustic hearing and
asymmetrical stimulation. We will examine these two types of perceptual abilities at ages when these skills are
thought to be fully-developed and can be reliably assessed. Aim 1a: Determine whether early acoustic hearing
contributes to AV perception and binaural listening skills. Aim 1b: Determine the unique contributions of AV
perception and binaural listening skills to spoken language, quality of hearing, and social functioning. Aim 2:
Determine if contributions of early suprasegmental perception to receptive language extend to adolescent-age
verbal skills, reading comprehension and self- and peer-rated hearing and social skills.

Public health relevance
Project Narrative: This study attempts to establish the independent contributions of early acoustic hearing via audiovisual perception and binaural listening skills, to communication, academic and social functioning in adolescent CI recipients. These studies will eventually guide clinicians in making informed recommendations regarding early bimodal (HA/CI) use and the timing of potential bilateral cochlear implantation for pediatric CI recipients.